Genomics of rapid adaptation in the lab and in the wild

Project Summary Adaptation is the central concept in evolution and biology in general. I aim to build and quantitative and predictive theory of the adaptive process by focusing on interrelated empirical, computational, and theoretical studies of rapid adaptation in a range of systems. The MIRA grant will be supporting three specific umbrella projects that focus on: (i) inference of the dynamics of adaptation from genomic data, (ii) studies of rapid seasonal adaptation in Drosophila, and (iii) high throughput studies of adaptive mutation in experimental evolution studies in yeast.

Public health relevance
Project Narrative Evolutionary adaptation is the central concept in biology and is at the heart of many problems facing humanities such as cancer and infectious disease. Using a series of interrelated projects Petrov lab will pursue research aimed at building a predictive and quantitative theory of adaptation.